A mobile application to offer upfront healthcare prices and automated medical billing for socioeconomically disadvantaged Americans

Project Summary/Abstract
This SBIR Phase II (R44) grant application will leverage publicly available healthcare service pricing data (i.e.
emerging big data resources) to improve health information dissemination and utilization by minority health and
disparity individuals, small businesses and communities. The long-term goal is to reduce health literacy
barriers around the cost of healthcare and to simplify access to this information through an assisted mobile
application and secure short message service (SMS) that helps minority and disparity populations get the care
they need at a price they can afford. This will ultimately improve healthcare access and outcomes while
reducing the burden of medical debt.
Healthcare consumers today have limited information about the cost of a service until after it is rendered,
despite there being significant variability in the price of the same service depending on location and provider.
This makes it incredibly difficult for patients to make cost-informed choices about where to get healthcare or
check the accuracy of medical bills, contributing to the $195bn of medical debt that Americans are burdened
with. Minority health and disparity populations are disproportionately impacted by this, with Black Americans,
Hispanic Americans and those below the federal poverty level (FPL) more likely to carry medical debt [1].
Soaring healthcare costs and the considerable impacts to minority health and disparity populations have
resulted in significant legislative changes to enable healthcare price transparency through mandating public
access to pricing data and shopping tools. The overall objective of this SBIR Phase II (R44) research
proposal is to create a legislatively compliant healthcare service cost estimator and billing management mobile
application, with bilingual and SMS capabilities to assist minority health and disparity populations in America
find affordable healthcare and pay accurate medical bills. The technical feasibility of this solution has been
validated in Phase I of the research, through preliminary development of a cost estimator and billing
management application focused on prices of hospital services only. The proposed Phase II research will build
on the preliminary findings and achieve the overall objective through four key aims: Aim 1: Assemble a
national pricing database of healthcare services prices published by health plans, using cluster computing to
enable high-volume data ingestion; Aim 2: Develop a multi-dimensional healthcare cost estimator for service
quote building and approvals across multiple parties for Good Faith Estimates; Aim 3: Integrate a
multi-language friendly content management system and HIPAA-compliant short message service (SMS) to
support a bilingual (English and Spanish) application and ayschronous communication capabilities; Aim 4:
Validate the usability of the advanced Cost Estimator and Billing Management Application (aCEBA) and its
effectiveness in improving access and affordability of healthcare for socioeconomically disadvantaged
populations.

Public health relevance
Project Narrative Variation in, and limited access to, healthcare service pricing is a significant contributor to the unsustainable growth of out-of-pocket costs for minority health and disparity populations, leading to avoiding necessary healthcare, significant medical debt and financial stress. Revealing price variation and medical billing discrepancies through consumer-friendly applications with bilingual care navigation assistance can reduce health literacy barriers around the cost of healthcare and improve access and affordability. The purpose of this research is to develop a legislatively compliant, bilingual healthcare services cost estimator and billing management mobile application, powered by a national healthcare pricing database and multidimensional search and quote building technology guided by SMS support.